Neuroimmune dynamics involved in the pathogenesis of hypertension after psychological trauma

PROJECT SUMMARY
Post-traumatic stress disorder (PTSD) is a debilitating psychological condition that increases the risk of
life-threatening comorbid inflammatory diseases such as hypertension by over 50%. The goal of this project is
to focus specifically on the neurological-T-lymphocyte mechanisms that regulate psychological trauma-induced
inflammation and the predisposition to hypertension. Previous results from our laboratory using a preclinical
model of PTSD known as repeated social defeat stress (RSDS) have demonstrated splenic T-lymphocytes as
a primary source of inflammation after psychological trauma. Furthermore, we identified that RSDS-mice
display a heightened blood pressure response to angiotensin II (AngII), which mimics the cardiovascular
disease sensitization observed in PTSD patients. Importantly, mice lacking T-lymphocytes were not sensitized
to AngII, which implies T-lymphocyte-driven inflammation as a mechanistic regulator of blood pressure after
RSDS. We have additionally elucidated tight links between pro-inflammatory cytokine production from T-
lymphocytes, sympathetic nervous system activation, the mitochondrial redox environment (primarily
superoxide) in T-lymphocytes, anxiety-like behavior, and the development of a blood pressure sensitization to
AngII, which suggests these physiological elements are mechanistically-intertwined. Given this information, we
will test the central hypothesis that increased sympathoexcitation after RSDS drives splenic T-
lymphocyte inflammation through increased mitochondrial superoxide to enhance sensitivity to
hypertension. Our Specific Aims will determine neuroimmune pathways and intracellular mechanisms that
control T-lymphocyte inflammation in the RSDS model of PTSD. The innovation in this proposal lies in the
concept of central and local autonomic control of T-lymphocytes regulating blood pressure sensitization, the
biological identification of mitochondrial superoxide regulating T-lymphocyte inflammation after psychological
trauma, and the technological advances of our new genetically-engineered animal models and
neuromodulation techniques. Overall, this project will reveal the impact of T-lymphocyte inflammation after
psychological trauma, and aims to utilize this evidence to inform clinical management of PTSD via earlier
cardiovascular screening or targeted therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Psychological trauma, and its pathological sequelae known as post-traumatic stress disorder (PTSD), increases the risk of developing cardiovascular diseases including hypertension by over 50%. Understanding that inflammation is a major regulator of hypertension, the main objective of this grant is to identify how psychological trauma initiates inflammation to lead to hypertension. Interventions that attenuate inflammation after psychological trauma may prevent life-threatening cardiovascular events in patients with PTSD.